PLANNING AND EVALUATION

The Cancer Center at the University of Texas Health Science Center at San Antonio requests $35,200 in support of the Planning and Evaluation process. The Cancer Center has both an External Advisory Board (EAB) and three Internal Advisory Committees, the Executive Committee (EC) for the day to day management, the Scientific Leadership Committee (SLC) for scientific programs and shared resources development and review and the Internal Advisory Committee for more global issues related to the various Schools and the UTHSCSA in general. The Cancer Center Director and leadership interact very closely with it's EAB through many telephone conferences, sending documents for review on a regular basis by on-site visits by the Chair, Dr. John C. Ruckdeschel, members of the EAB and by an annual visit of the EAB. the EAB reviews and advices Director on all activities of the Cancer Center. Their reviews, evaluations and criticisms have led us to develop much stronger Cancer Center Funds to support the EAB are requested ($25,000). The EC and the SLC work very closely together and with the EAB for Strategic planning and evaluations of the programs and shared resources. The Cancer Center uses center-wide retreats and program retreats to further develop strong and effective programs and shared resources and for future recruitment strategies. We request $10,000 to help with the Cancer Center and program retreats.

Public health relevance
The CTRC is in a historic period of transition and re-growth after a period of turnnoil and attrition of key personnel. Planning and evaluation funds are critical to maintain our ability to bring in our EAB, and to compensate them for the visits and for grant reviews. Funds for retreats and other meetings of programs are also to maintain the momentum generated by the merger and by the new leadership. These funds help rebuild and further strengthen programs through appropriate planning and evaluation during a transition period.